Predicting ASD and Other Developmental Outcomes in the First Year of Life Using EEG in a Diverse Community-Based Sample (Revision)

Project Summary
Children growing up in disadvantaged, high-stress environments are at a significantly increased risk for
developmental delays and autism. Early identification of those at greatest risk is crucial to improving outcomes.
There is mounting evidence from our laboratory that there are patterns in the EEG that emerge during the first
year of life that are reliably associated with autism outcomes at 2-3 years of age. The primary goals of the parent
grant (NS120986) thus extend our previous work (DC010290) by collecting high-dimensional EEG data
collection in a large pediatric primary care clinic, thus demonstrating the potential scalability of EEG as a
biomarker of autism risk. Importantly, the study is situated in a clinic serving infants who have historically been
underserved and understudied: primarily Black and Hispanic infants growing up in low-income homes. The
parent study collects EEGs during infant well-child visits at 4, 9, and 12 months, with diagnostic outcomes
assessed at 24 months using the Mullen Scales of Early Learning (MSEL), Rapid Interacting Screening Test
for Autism in Toddlers, the Autism Diagnostic Observation Schedule (ADOS), and the Vineland Adaptive
Behavior Scales. In addition to EEGs, data collected as part of the parent study include parent report of
development, temperament, and parental perceived stress, along with demographic information and medical
record abstraction.
Prior to launching this study, our preliminary data suggested that infants born into low income and high
stress households have a higher prevalence of both autism (10%) and developmental delay (20%) at 24
months. However, our preliminary data thus far suggest even higher rates of autism (19%) and developmental
delays (41%). These rates are concerning and it is imperative that we further characterize whether the pattern
of findings to date persists through 3 years of age. The goal of this competing revision is to extend the parent
project to evaluate developmental progress of our enrolled participants, from 24- to 30- to 36-months in order
to better characterize the stability of early symptoms of autism and developmental delays.
Aim 1a: Evaluate the stability of autism symptoms from 24- to 30- to 36-months in our enrolled sample of
children raised in low resource families.
Aim 1b: Evaluate the stability of language and developmental delay from 24- to 36-months in our enrolled
sample of children raised in low resource families.
Aim 2: Exploratory aim to compare EEG features in autistic toddlers who do and do not exhibit substantial
improvement in symptoms between 24-36 months.
These additional evaluations will be critical to furthering our understanding of biological and
environmental factors influencing early development in this underserved, understudied, high risk population.

Public health relevance
Narrative In the Baby Steps study (NS120986) we are collecting high-dimensional EEG in a large and diverse pediatric primary care clinic, thus demonstrating the potential scalability of EEG as a biomarker of autism. An alarmingly high percentage of enrolled infants are meeting criteria either for developmental delay or autism at 24 months. The current application extends the parent grant to examine the stability of autism symptoms and developmental delays across 24-, 30-, and 36-month visits, and to compare EEG features in autistic toddlers who do or do not exhibit significant improvement between 2- and 3-years of age.